Bone and fat cross-talk in antiretroviral therapy (ART) treated HIV patients

Project Summary / Abstract
The widespread use of combination antiretroviral therapy (cART) has significantly increased the lifespan of
people living with HIV (PLWH). As HIV has become a chronic disease, there is a growing concern of the
disproportionate risk of a variety of comorbidities. In our parent award, we are focused on two comorbidities
that occur at a higher prevalence in cART treated PLWH - bone loss and fat gain. Our proposal focuses on the
contribution of antiretrovirals to the development of these two conditions and utilizes a novel preclinical mouse
model of HIV infection and cART treatment and human subjects data from a large-scale NIH-funded cohort
study of PLWH. The current administrative supplement seeks to leverage these ongoing studies to extend our
efforts into pain research and to generate supporting evidence towards a future scientific direction in
pain research. Specifically, we seek to investigate musculoskeletal pain, which is a common concern of
PLWH in patient reported outcome studies. We will leverage our ongoing animal work to investigate the
biological mechanisms (Aim 1) and our ongoing collaboration with the MWCCS to obtain define the joint-
specific patterns of musculoskeletal pain in women living with HIV (Aim 2). If successful, the supplemental
aims will generate exciting new data on the prevalence and potential risk factors for musculoskeletal pain
development in PLWH and provide the PI with experience and preliminary data to further research pain
mechanisms in this vulnerable population. Importantly, the supplemental aims align with several areas of
scientific interest within NIAMS, including focusing on immune mechanisms of pain, making large data
sets relevant to pain research, and leveraging existing datasets for secondary analysis for pain
research.

Public health relevance
Project Narrative Musculoskeletal pain is a common complaint in people living with HIV and it is particularly evidence as this population ages. The current proposal will investigate the biological mechanisms of musculoskeletal pain development and determine the functional consequences of musculoskeletal pain in people living with HIV.